Structural biology of DNA damage response in chromatin

Summary/Abstract
When DNA is damaged, cells activate a complex network of proteins that sense, signal, and initiate repair. This
DNA damage response (DDR) also encompasses mechanisms for DNA damage tolerance, enabling cells to
replicate damaged DNA. In eukaryotes, the DDR operates within chromatin, consisting of repeating nucleosomes
where histone proteins and DNA serve as docking surfaces for DDR proteins. Central to signaling DNA double-
strand breaks (DSBs) is the mammalian E3 ubiquitin ligase RNF168. RNF168 catalyzes the ubiquitylation of
histone H2A and variant H2AX at DSB sites, regulating the recruitment of several DDR proteins to chromatin,
including those involved in homologous recombination or homology-directed repair (HDR). Despite progress in
understanding RNF168-mediated signaling, key gaps remain, particularly regarding the function and
mechanisms of action of E3 ubiquitin ligase RAD18, one of the effector proteins of RNF168. The central
hypothesis of this proposal is that downstream effectors of RNF168 integrate DNA damage repair with DNA
damage tolerance, focusing primarily on the E3 ubiquitin ligase RAD18. RAD18 is unique in its involvement in
both HDR and DNA damage tolerance pathways. The planned research will investigate the role of RAD18 in
HDR and other repair pathways activated by replication stress using integrative structural biology, including
single-particle cryo-electron microscopy (cryo-EM), NMR spectroscopy, X-ray crystallography, biophysical
approaches, chemical biology, and collaborative cell biology. Specifically, the nucleosome association of RAD18
and of chromatin maintenance proteins recruited in a RAD18-dependent manner will be characterized.
Additionally, mechanisms through which RAD18 and cognate E2 ubiquitin-conjugating enzyme RAD6 promote
DNA damage tolerance via the mono-ubiquitylation of DNA sliding clamp PCNA will be examined. The research
will also explore a mechanism involving RAD18-RAD6 that integrates elements of both DSB repair and DNA
damage tolerance through PCNA-ubiquitylation-directed homologous recombination. Overall, this work will
contribute fundamental knowledge that enhances the understanding of DNA damage repair and tolerance
mechanisms, including how they are integrated. Given the importance of the DNA damage response in
maintaining genomic stability and preventing diseases such as cancer and neurological disorders, these studies
are expected to yield new findings that will have long-term benefits for human health. During this research, it is
probable that unexpected and intriguing new questions will arise, and some of these may be addressed under
the flexibility afforded by the MIRA mechanism.

Public health relevance
Narrative The proposed research seeks to improve understanding of the mechanisms by which DNA damage repair and tolerance operate, providing insights into fundamental genome maintenance processes. Such studies are relevant to public health because the knowledge they will generate has the potential to inform long-term strategies for combating human diseases like cancer, immunodeficiency, and neurodegenerative disorders.